Evaluate the Safety, Tolerability, and Immunogenicity of Adjuvanted Preventive Dual Aβ/tau Vaccine, Duvax in Healthy Volunteers

Project Summary
Alzheimer's disease (AD) represents the most prevalent form of dementia, characterized by memory impairment
and changes in multiple cognitive functions. This complex condition arises from a blend of genetic and
environmental influences, culminating in hallmark pathologies like β-amyloid (Aβ) oligomers/fibrils/plaques and
tau aggregates/tangles, followed by inflammation and severe neurodegeneration. The modern "amyloid
cascade" hypothesis emphasizes the pivotal role of Aβ oligomers in initiating tau pathology and subsequent
inflammatory responses, oxidative stress, and synaptic and neuronal loss, while the accumulation of pathological
tau is directly correlated with the disease progression and severity. Therefore, the development of potential
therapies for AD has been mainly focused on reducing pathological Aβ or tau and, more recently, on inflammation
associated with accumulating these pathological molecules in the brain. Increasing evidence underscores the
synergistic pathogenic interaction between Aβ and tau, sparking interest in therapies concurrently addressing
both. Scientists from the Institute for Molecular Medicine (IMM) advocate for an immunogenic dual vaccine
targeting both Aβ and tau pathologies, deeming it optimal for inhibiting Aβ aggregation, reducing tau
accumulation, and potentially delaying clinical AD onset. This vision led to the creation of Duvax, an adjuvanted
(AdaxCpG), MultiTEP vaccine platform-based dual vaccine, demonstrating promising immunogenicity and
efficacy in rigorous AD mouse models. They finalized all FDA-required IND-enabling studies, including: (i)
manufacturing of cGMP recombinant protein (drug product) with CMC information; (ii) safety/toxicology studies
of Duvax in disease model of Tg mice. Nuravax, Inc., having licensed Duvax, collaborates with IMM and
proposes in phase 1 of this program (R43) to define the safe and immunogenic optimal dose range of Duvax in
non-human primates, concurrently preparing and submitting the IND30496 application to the FDA for Phase 1
safety and immunogenicity trials in healthy human subjects. Transitioning into phase 2 (R44), Nuravax plans a
randomized, double-blind, placebo-controlled study to evaluate Duvax's safety/tolerability and immunogenicity
in male and female healthy volunteers aged 40-65 years. Completion of this comprehensive study will provide
essential data supporting future Phase 2 trials tailored for age-matched preclinical AD populations, advancing
our comprehension and potential treatment avenues for this debilitating condition.

Public health relevance
Project Narrative Phase 1 (R43) of this project aims to assess the overall safety and determine the optimal dose range of the Duvax vaccine targeting Aβ/tau in non-human primates and submit IND30496 to the FDA for clearance to conduct the Phase 1 safety and immunogenicity trial of the first-in-human adjuvanted Duvax vaccine in healthy participants. In Phase 2 (R44), we will conduct a randomized, double-blind, placebo-controlled study to evaluate the safety/tolerability (primary outcome) and immunogenicity (secondary outcome) of Duvax in two ascending dose cohorts of male and female healthy volunteers aged 40-65 years. Completion of this study will provide critical data to support future Phase 2 trials involving age-matched preclinical AD individuals.